A Mentoring Program in Kidney Care for Older Adults

PROJECT SUMMARY/ABSTRACT
This proposal for a Midcareer Investigator Award in Patient-Oriented Research (K24) will
support the research program of Dr. Manjula Kurella Tamura, a nephrologist at Stanford
University and Director of the Veterans Affairs Palo Alto Geriatric Research and Education
Clinical Center. The candidate leads a multi-disciplinary research program which is focused on
patient-centered outcomes of dialysis treatment in older adults. Her research program,
comprised of a health services component and an interventions component, has been
supported by five federally funded awards during the past five years, and has produced an
extensive portfolio of work to support hypothesis driven mentee research. During this time, the
candidate’s research program has provided training opportunities for 13 junior investigators who
have successfully obtained funding, published research in high-impact journals, and transitioned
into academic positions. In this K24 application, her overarching goal is to grow and sustain this
program by: (1) enhancing her skills as a research mentor by obtaining training in key areas,
and (2) using her research as a platform to mentor trainees from a range of disciplines, and (3)
extending her research to evaluate treatment trade-offs earlier in the course of kidney disease.
Recent clinical trials demonstrate that intensive versus standard blood pressure targets reduce
mortality and cardiovascular events, but at the expense of kidney function. The scientific goal of
this application is to evaluate the comparative harms and benefits of intensive versus standard
hypertension treatment and hypertension deprescribing on kidney end-points in two real world
older adult cohorts. The secondary goal is to demonstrate the application of novel analytical
approaches that extend causal effects from randomized trials to older and sicker populations.
The candidate’s mentoring program will integrate resources from the breadth of training
programs at Stanford and VA Palo Alto, with unique opportunities tailored to the career
development of scientists in aging research.

Public health relevance
Candidate: Kurella Tamura, Manjula PROJECT NARRATIVE The proposed K24 Midcareer Investigator Award ‘A Mentoring Program in Kidney Care for Older Adults’ will support a multi-disciplinary research program and train the next generation of patient-oriented researchers. Building on a track record of successfully mentoring junior investigators, this proposal will enable the candidate to dedicate more time to mentoring trainees, gain new skills that will expand the scope of her research, and conduct new research that will extend evidence from large clinical trials in hypertension and kidney disease to evaluate the comparative risks and benefits of intensive blood pressure targets in real world older adults.